Identifying a novel pathway that regulates RA immunometabolism

Rheumatoid arthritis (RA) is the most common autoimmune disease, which affects 2.5 million people in the
US. It has been shown that joint monocyte infiltration and differentiation into inflammatory macrophages (MΦs)
play a key role in disease progression. Patients with a positive response to RA therapy, exhibit a reduced number
of MΦs, joint inflammation, pain & radiological damage. In contrast, in non-responsive patients, the number of
inflammatory MΦs is expanded along with skewed metabolic rewiring towards glycolysis and away from
mitochondrial oxidative phosphorylation. Hence, to find a novel therapeutic strategy, there is a critical unmet
need to elucidate the molecular mechanism by which naïve joint cells are reprogrammed into glycolytic RA MΦs.
We show for the first time, that a specific cytokine rewires the naïve M0 cells into glycolytic MΦs that
produce high levels of inflammatory monokines and metabolites. Notably, these glycolytic MΦs are primed to
differentiate into mature osteoclasts. Notably, dysregulation of syndecan (SDC)1 impairs secretion of the
inflammatory monokines, polarization of the glycolytic CD14+CD86+GLUT1+ MΦs, and remodeling of the
primed glycolytic cells into mature osteoclasts facilitated by the cytokine of interest.
Based on these novel observations, we hypothesize that binding of the cytokine of interest to SDC1
reprograms the naïve cells into glycolytic MΦs and mature osteoclasts, and blockade of SDC1 or the activated
metabolic intermediates will attenuate arthritis. To test our hypothesis, we will determine if inhibition of the SDC1
or the identified glycolytic intermediates will impede the remodeling of naïve cells into metabolically active RA
MΦs and mature osteoclasts using the early and late-stage patients. Next, we will delineate if the adoptive
transfer of fully differentiated glycolytic MΦs can restore preclinical arthritis in the absence of metabolic factors
linked to SDC1. Last, we will investigate whether deregulation of SDC1 or the master regulator of glucose
metabolism will attenuate experimental arthritis. By integrating mechanistic RA cellular studies and preclinical
models, we aim to delineate pathways by which the metabolically active MΦs advance joint disease. Our
proposed approach will answer several fundamental questions including; 1) What are the metabolic machinery
activated in RA MΦs and experimental arthritis, 2) Whether RA MΦ-regulated inflammatory and erosive
phenotypes will be reversed by dysregulation of glycolytic intermediates and 3) Does targeting the
hypermetabolic activity in MΦs represents a new therapeutic approach for RA.

Public health relevance
There is no cure for RA and up to 50% of the RA patients do not respond to current therapies. To resolve the critical barrier in RA treatment, we have identified a ligand and receptor pair that plays a central role in promoting joint inflammation and bone erosion, and their expression is strongly linked to RA disease activity. The goal of this proposal is to understand the mechanism of action for the identified pathogenic ligand and receptor and to examine whether dysregulation of their function or the associated metabolic pathways can be utilized as a promising strategy for RA therapy.